FXTAS Key Molecular Pathways Converge with Other Neurodegenerative Disorders

PROJECT SUMMARY/ABSTRACT
THE CANDIDATE. Dr. Lozano is an early career physician-scientist, who has drawn on his academic
achievement and diverse training in clinical and basic science to develop an independent research program.
Through his work, he has developed laboratory skills in genetics and molecular biology, as well as clinical
research which together form the foundations of this ongoing project.
CAREER DEVELOPMENT. Dr. Lozano's overall long-term career goal is to lead a meaningful and sustainable
research program that will allow him to remain a well-established and independent investigator in the area of
Fragile X-related disorders. These goals will be accomplished through intense mentorship (Drs. Alison Goate
(mentor), Bin Zhang (co-mentor), and George Diaz(co-mentor)), meaningful collaborations, and personalized
didactic mechanisms, which are outlined in this application.
INSTITUTIONAL ENVIRONMENT. The Department of Genetics & Genomic Sciences at the Icahn School of
Medicine at Mount Sinai is a hybrid world-class basic science and clinical program that offers a broad-based
program of instruction, research, and clinical services. The faculty are experts in the application of molecular
biology, data science, and somatic cell approaches for the study of genetic diseases. The environment
provided in the department is ideal for the execution of the studies outlined in this application.
RESEARCH PROJECT. There
In
understood.
the
hypothesis
the
in
RNA
transcriptome
mechanisms,
To
with
sclerosis/Frontotemporal
FXTAS
determine
are currently no effective treatments for neurodegenerative disorders (NDDs).
order to develop potential therapeutic targets the underlying biological mechanisms mus be more clearly
Fragile X-associated tremor/ataxia syndrome (FXTAS) ffers an opportunity to gain insights into
pathological mechanisms for an NDD disorder that stems from a defined genetic etiology. The overall
is that protein clearance deficits are exacerbated by polypeptides and mRNA-FMR1 produced from
CGG expansion. This results in neuronal response-driven increases in ubiquitin proteins that are deposited
inclusions, leading to cell dysfuction, reactive inflammatory microglial and eventually neurodegeneration
sequencing (bulk and single nuclei) will be used to qualitatively and quantitatively examine the
in postmortem human tissue. Since NDDs involve complex and intertwined biological
an unbiased and hypothesis-free approach for key molecular pathways discovery will be applied.
identify the converging pathologica l processes in NDDS, the novel FXTAS datasets will be cross-examined
available datasets of Alzheimer's Disease, Parkinson Disease and amyotrophic lateral
ementia . This tudy has the potential to not only identify critical mechanisms driving
pathogenesis that would acilitate the discovery of biomarkers and therapeutic targets but also
pathways most central to disease through a cross-examination approach with other NDDs.
, t
o
.
d s
f

Public health relevance
NARRATIVE Fragile (NDD) that regulate single-cell investigate potential drug X-associate shares brain cellular-specific aggregation of proteins and ubiquitin, which have been shown to the degradation of proteins and inflammatory signaling in other NDDs. In this study, we use bulk and high-resolution profiling of transcriptional alterations in post-mortem brain samples of FXTAS to the role of the ubiquitin pathway in FXTAS in comparison with other NDDs. This which study has the to identify critical mechanisms driving FXTAS can be exploited for biomarker discovery and target identification in FXTAS and more broadly in NDDs. Tremor Ataxia Syndrome (FXTAS) is a devastating late-onset neurodegenerative disorder